Bioactive Metabolites Modulate Immune-Related Adverse Events in Cancer Immunotherapy

Project Summary
Immune checkpoint blockade (ICB) therapy has demonstrated significant clinical benefit in late-stage patients
with melanoma, renal cell carcinoma, head and neck cancer, Hodgkin lymphoma, bladder cancer, non-small
cell lung cancer, gastric cancer, liver cancer, cervical cancer, Merkel cell carcinoma, and for all microsatellite-
unstable tumors. A major limitation of ICB therapies targeting the CTLA4 or PD1 immune checkpoints is that a
significant portion of patients will experience immune-related adverse events (irAEs), which can result in
permanent or even fatal toxicity and discontinuation of life-saving immunotherapy. Compounding this problem
is the fact that there currently exist no molecular modulators for ICB-driven irAEs. This R01 application
examines circulating LPC 18:2 a novel small molecule modulator and therapeutic for irAEs by studying human
cancer patients and relevant preclinical models of ICB-driven irAEs and tumor regression. The proposed aims
will systematically i) examine association between LPC 18:2 and irAEs across multiple human cancer cohorts
(e.g. melanoma, non small lung cancer, head and neck squamous cell carcinoma) and ICB therapies (e.g. anti-
CTLA4 ipilimumab, anti-PD1 pembrolizumab and combination therapies); ii) examine relationship between
plasma LPC 18:2 levels and ICB-driven tumor regression or natural autoimmune disease; iii) study the
immunological mechanisms by which LPC 18:2 restrains ICB-driven irAEs and autoimmune colitis; iv)
mechanistically probe novel effects of LPC 18:2 and LPC-G2A signaling on development and function of
inflammatory neutrophils. This study uses a highly innovative approach leveraging cancer patient bio-sampling
across multiple independent clinical trials with state-of-the-art rapid mass spectrometry profiling of small
molecule metabolites and mechanistic studies. This is a collaborative study between a cancer immunologist
and basic scientist at La Jolla Institute for Immunology and UCSD Moores Cancer Center, an analytical
chemist at UCSD, a statistical epidemiologist at Cedars-Sinai Medical Center, clinical immune-oncology
collaborators and experts on fundamental immunology and neutrophils. Validating LPC 18:2 as a therapeutic
molecule for irAE toxicities addresses an urgent need at the clinical level to develop the very first therapies that
can minimize risk, maximize benefit, and more accurately personalize ICB therapies for those patients who
stand to benefit from cancer immunotherapy.

Public health relevance
Project Narrative This R01 grant proposal addresses a critical unmet need, exploring LPC 18:2 as a novel small molecule therapeutic for immune related adverse events (irAEs) in cancer patients undergoing immune checkpoint blockade (ICB) therapy for cancer. We are leveraging a powerful, discovery-based metabolomics platform in human cancer patients combined with mechanistic studies in humans and preclinical models to understand molecular mechanisms by which LPC 18:2 protects against ICB-driven irAEs. This study will directly enable LPC 18:2 therapy to alleviate irAEs and minimize risk, maximize benefit, and personalize cancer immunotherapy for those patients who stand to benefit from these powerful treatments.